Biostatistics Core Facility

The Biostatistics Core Facility (BCF) provides state-of-the-art statistical support for University of Chicago Medicine Comprehensive Cancer Center (UCCCC) investigators engaged in clinical, translational, basic, and population sciences research. BCF helps UCCCC investigators meet their scientific research objectives by ensuring that studies are adequately powered, and that the data are appropriately analyzed and interpreted. Careful consideration of sources of variation, variability, multiplicity, and potential confounding variables is needed to reduce false positive (and false negative) findings. Appropriate study design also reduces the occurrence of equivocal findings. Input into data collection and data management processes can reduce errors, prevent or reduce the amount of missing data, and improve overall data quality. BCF collaborates closely with UCCCC investigators to attain these goals. The services provided include: (i) assistance with study design and data analysis plans; (ii) protocol development, randomization, and statistical analysis for phase I, phase II, and phase III clinical trials; (iii) assistance in the design and analysis of retrospective and prospective observational studies; (iv) analysis of genomic and other high-dimensional data; (v) statistical analysis support for basic science and animal research projects. Advances in statistical methodology related to cancer research is also an important goal. In the current CCSG cycle, BCF has supported 86 unique UCCCC members, 82 clinical trials, 32 peer-reviewed cancer-related grants (78% NCI) and 180 peer reviewed publications (28% in journals with impact factor ≥ 10).
In summary, the BCF is dedicated to providing UCCCC investigators with high-level statistical support to facilitate cancer research and to meet the goals of the Strategic Plan.